Neural Mechanisms of Premature Ventricular Contraction-Induced Cardiomyopathy Revealed by Targeted Neuromodulation of the Cardiac Neuraxis

Frequent premature ventricular contractions (PVCs) can cause PVC-induced cardiomyopathy (PVC-CM),
precipitate arrhythmias, induce heart failure and increase cardiac mortality. However, the mechanisms remain
unclear. Current therapies rely solely on PVC suppression but this may not be viable in many patients nor
sufficient to reverse neuro-cardiac remodeling which may persist to induce ongoing harm through autonomic
dysregulation (sympathetic overload and sympathetic/parasympathetic dysfunction). We hypothesize that
PVCs induce neural remodeling which is a critical mediator that promotes cardiac remodeling (PVC-CM) and
confers arrhythmogenesis via autonomic dysregulation. Neuromodulation protects against neural remodeling
thereby prevents or restores PVC-CM and suppresses arrhythmias (Central Hypothesis). Through a novel
chronic de-afferentation model of sino-aortic afferent denervation (SAAD), we will (Aim 1) test the hypothesis
that the afferent neural mechanism of PVC-CM is an arterial baroreflex “sensory” overload triggered by
frequent PVCs and mediated via SAA nerves. SAAD dampens baroreflex overload and protects against PVC-
CM. We will also (Aim 2) test the hypothesis that the efferent neural mechanism of PVC-CM is an efferent
sympathetic overload triggered by PVCs, hence bilateral vs unilateral efferent cardiac sympathetic denervation
(CSD) incrementally protects against PVC-CM by providing graded cardiac shielding against sympathetic
overload, thus re-purposing a clinically approved anti-arrhythmic treatment (CSD) to novel use of cardio-
protection against sympathetic overload. As a counterpart to surgical approaches, we will (Aim 3) test the
hypothesis that carvedilol protects against PVC-CM via downstream beta-blockade as well as via novel and
pleiotropic neuro-modulatory effects by reducing sympathetic nerve activity, cardiac adrenergic overload and
preserving baroreflex and efferent autonomic function by restoring intrinsic cardiac neurotrophy suppressed by
PVCs. Translationally, we will also employ therapeutic vs pre-emptive neuromodulation approaches. In-vivo
electrophysiologic studies will assess protection from cardiac electrical remodeling and arrhythmogenesis while
serial echocardiography will assess impact on cardiac structural remodeling. Novel chronic ambulatory cardio-
neural-BP telemetry can assess neural remodeling across 4 different neural sites correlating with BP, heart
rate variability and spontaneous arrhythmogenesis. Novel provocative “dual stressor” PVC and vasopressor
challenge will assess the novel contribution of dynamic baroreflexes to PVC-CM, while “dual stressor” exercise
and PVC challenge will protection against efferent sympathetic and parasympathetic dysfunction. Cellular-
molecular and in-vitro studies will assess the impact on intrinsic vs extrinsic neural remodeling and intracellular
calcium remodeling. This study will provide novel proof-of-concept that autonomic remodeling/dysregulation
causes PVC-CM and pro-arrhythmia, map critical neural signaling pathways (afferent, efferent, downstream) in
the PVC-neural loop thus identify novel therapeutic targets as alternative therapies to PVC suppression.

Public health relevance
The main goals of this proposal are to prove the causal link between neural remodeling, characterized by sympathetic overload and sympathetic and parasympathetic dysfunction, with PVC-induced cardiomyopathy (PVC-CM), and to evaluate the afferent, efferent and downstream mechanisms by which PVCs promote neural and cardiac remodeling. By using two surgical approaches (afferent, efferent denervation) and one pharmacological neuromodulation with both beta-blocker and known neuro- modulatory effects (carvedilol), we can elucidate the up and downstream signaling pathways perturbed by PVCs and provide for the first time, proof-of-concept that neuromodulation can be cardio- and neuro-protective against chronic frequent PVC exposure, with beneficial effects that include preventing PVC-CM, arrhythmias and restoring sympathetic-parasympathetic function. By filling this knowledge gap, we can fulfill the critical unmet need to broaden the current therapeutic regimen beyond PVC suppression only, which may not be feasible nor sufficient to protect against the increased morbidity and mortality of PVC-CM and frequent PVC syndrome.